The neural basis of visual snow syndrome

PROJECT SUMMARY
Visual Snow Syndrome (VSS) is a poorly understood neurological condition whose primary symptom is the
constant perception of flickering specks, like television static, superimposed on the visual world. VSS can be
debilitating, interfering with daily life activities such as reading and driving. The cause of this condition remains
unknown, and there are currently no effective treatment options. Our proposal builds on our recent discovery
that a method called visual adaptation can temporarily alleviate visual snow symptoms. This exciting revelation
gives us a powerful new tool for understanding the neural basis of visual snow. In this proposal, we will test the
hypothesis that VSS is caused by excess spontaneous neural activity within visual brain areas. To do so, we
will compare behavioral tests of visual perception using adaptation in people with VSS versus normally sighted
control participants, as well as non-invasive measurements of neural activity (functional magnetic resonance
imaging) and brain chemistry (magnetic resonance spectroscopy). Understanding where and how spontaneous
neural activity leads to visual snow percepts will pave the way for new treatment strategies, objective tests, and
biomarkers for VSS, which may in turn improve quality of life, diagnosis, and evaluation of treatment efficacy in
this disorder.

Public health relevance
NARRATIVE Visual snow syndrome is a condition in which people see a veil of flickering specks across their field of vision at all times, the cause of which is unknown. We have recently shown that the visual snow percept can be dramatically reduced using visual adaptation methods. Here, we will use behavioral tasks and MRI methods among people with VSS versus controls to test the hypothesis that the snow percept arises from spontaneous activity in the neural pathways, and to identify where and how this activity arises.